Impact of COVID-era Disrupted Care on Disparities in Outcomes among Veterans with Kidney Failure

Background: The COVID-19 pandemic significantly disrupted care delivery that limited access to providers,
acute and timely non-acute evaluation, and clinical intervention. Dialysis patients with kidney failure are
particularly vulnerable to COVID-19 infection, COVID-19 related morbidity and mortality because they commonly
have multiple chronic conditions, typically require thrice weekly life-sustaining dialysis treatment in close-
quartered clinic settings, are already prone to fragmented care, and especially susceptible to disrupted care. The
COVID-19 pandemic presents fundamental threats to dialysis patients, and there is an urgent need to examine
the impact of disrupted care for this vulnerable and uniquely healthcare reliant population of patients.
Over 16,000 of enrolled Veterans receive chronic dialysis through Veterans Health Administration (VA)
Kidney Program’s VA and VA Community Care providers. VA Community Care improves access to life-
sustaining dialysis services for 80% of Veterans with kidney failure with limited access to the VHA’s 70 dialysis
units. In prior work, we found lower 2-year mortality among Veterans receiving dialysis exclusively in VA
compared to those receiving dialysis in non-VA settings, consistent with VA and non-VA comparative studies in
other clinical contexts. These differences may be due to more comprehensive integrated services (e.g., co-
located primary and tertiary care services, care management, social work, national electronic medical record) in
VA, compared with the more fragmented and siloed dialysis care in private sector community settings.
Significance: Pandemic-related disruptions may disproportionately affect Veterans with serious conditions and
social risk factors like those with kidney failure and the nature and impact of pandemic-related disruptions may
differ in VA and non-VA systems. However, rigorous comparisons of COVID-related care disruptions and
outcomes between Veterans receiving healthcare in VA and non-VA settings are lacking.
Specific Aims: Building on our team’s research expertise, this study will:
1) Quantify the impact of COVID-19 on 1a) disrupted care for prevalent patients and 1b) deferred care for incident
patients in a national cohort of Veterans with ESKD and compare the extent of these impacts between VA-
financed dialysis care in VA and VA Community Care settings from 2018-2022.
2) Compare patient-level outcomes and racial and socioeconomic disparities in outcomes in VA and non-VA
dialysis settings before and during the COVID pandemic time periods.
Methodology: We will conduct a longitudinal cohort study of all VA-enrolled patients with end-stage kidney
disease receiving VA-financed dialysis care between 2018 and 2022, to observe care patterns before the pre-
COVID phase (Jan 2018-Feb 2020), the acute COVID phase defined as the first case of COVID until
authorization of the vaccine (Mar 2020-Dec 2020) and the recovery phase when COVID-19 vaccination was
available (Jan 2021-Dec 2022). Study data will be derived from linkages of VA and Medicare administrative data
with community-level national COVID-19 tracking and neighborhood socioeconomic status data to assess the
impacts of pandemic-related disruptions in care on disparities in outcomes among Veterans receiving dialysis in
VA and non-VA settings.
Next Steps/Implementation: This research is directly responsive to the COVID RFA HX-21-025: Pandemic
related disrupted and deferred care and three VA HSR&D priority areas (Access to Care, Complex Disease
Management, Social Determinants of Health). The study team is conducting this work partnership with the VHA
National Program for Kidney Disease to ensure that our work is poised to shape evolving VA policy around
provision of community care and to improve care for Veterans during the COVID-19 pandemic, recovery, and
future public health crises. Results will inform how VA manages its Veterans in disaster scenarios, particularly
with provider partners in VA community care, for whom the VA relies on for reliable and accessible dialysis care.

Public health relevance
The COVID-19 pandemic presents fundamental threats to dialysis patients. Over 16,000 of enrolled Veterans with ESKD receive VA-financed dialysis, 80% of whom receive this life-sustaining treatment through VA Community Care providers. Prior work found lower rates of survival among Veterans receiving dialysis exclusively in non-VA settings compared to VA dialysis, which may be due to fragmented and siloed care structures in community compared to the VA’s integrated healthcare system. Patients with kidney failure are particularly vulnerable to COVID-19 infection and related morbidity and mortality, are already prone to fragmented care, and especially susceptible to disrupted care. This study addresses an urgent need to examine the extent and impact of pandemic-related disruptions in care on disparities in outcomes among Veterans receiving dialysis treatment in VA and VA Community Care settings. Findings will inform how VA manages care for Veterans in disaster scenarios for this vulnerable and uniquely healthcare reliant population of patients.